RECOMBINANT ADENOVIRUS GENE TRANSFER IN ADULTS WITH PARTIAL OTC DEFICIENCY

To monitor safety and measure changes in ureagenesis resulting from gene therapy in patients with ornithine transcarbamylase (OTC) deficiency. OTC deficiency is an inborn error of urea synthesis inherited as a X-linked disorder. Current treatment relies on alternate pathway therapy or liver transplantation. A Phase I study of adenoviral mediated gene therapy is being carried out at the University of Pennsylvania on adult heterozygote, with this disorder. We are a collaborating institution in this study and will perform in the GCRC 1) heavy isotope (15N)/allopurinol studies to measure efficiency of the experimental treatment in correcting deficits in ureasynthesis; and 2) to obtain blood for liver, renal, hemotologic and immune function to study safety in objects with OTC deficiency.